Therapeutic targeting of the tumor microenvironment in triple negative breast cancer patients at high risk of relapse and preclinical models of lung metastases

Our long-term goal is to significantly improve outcome for patients (pts) with triple negative breast cancer (TNBC).
Tumor generated microenvironments in distal target organs provide hospitable sites (“pre-metastatic niches”)
that support metastatic colonization and outgrowth. Bone marrow-derived progenitor cells including VEGFR2+
EPCs and VEGFR1+ HPCs, copper (Cu) dependent lysyl oxidase (LOX) and collagen re-modelling constitute
underlying metastasis-supporting features of the pre-metastatic niche.
Our central hypothesis is that Cu depletion using tetrathiomolybdate (TM) prevents relapse by disrupting three
key aspects of metastasis: (1) cancer cell intrinsic mitochondrial bioenergetics that mediates
invasion/metastasis/chemoresistance, 2) the “pre-metastatic niche” that supports colonization, and outgrowth of
disseminated metastatic tumor cells, and (3) stromal remodeling that promotes immune evasion and
immunotherapy resistance. Strikingly, results from our phase II trial of TM in 75 breast cancer (BC) patients at
high risk for relapse showed TM decreased VEGFR2+EPCs, reduced circulating LOX levels by > 50% and
normalized the collagen microenvironment. Importantly, TM was well tolerated, and relapses were rare past four
years on study.
The objective of this proposal is to test this hypothesis by conducting a small phase Ib trial of adding 3 years of
adjuvant TM to standard 6 months treatment of adjuvant capecitabine and pembrolizumab in high risk for relapse
TNBC (RCB 2, 3, risk for relapse >60% at 5 years) after completion of neoadjuvant therapy and surgery to
establish the safety of the combination followed by a randomized phase II clinical trial of adjuvant TM and
capecitabine vs capecitabine alone. If pembrolizumab was administered in the neoadjuvant setting, it may be
continued in the adjuvant setting per investigator discretion. The primary endpoint is the effect of the addition of
TM on distant relapse-free survival (DRFS). Secondary endpoints include: (a) Overall Survival (OS) and invasive
disease-free survival (iDFS) between the two arms, (b) safety and tolerability of TM, (c) OS and iDFS in patients
that complete at least 6 months of TM (d) VEGFR2+ EPCs, LOXL2, ctDNA, (e) Patient-reported quality of life
(PROs) and (f) Pharmacokinetics in a sub-study cohort of patients (AIM 1).
AIM 2 exploratory translational endpoints include the effect of TM on single nucleotide polymorphisms of
ceruloplasmin, and CTR1 on the ability to Cu-deplete pts, the influence of ATOX1 and collagen biomarkers
(C1M, ProC3 and C6M) on DRFS and OS and the effect of copper depletion on immune biomarkers and the
metabolic profile of a selected cohort of patients enrolled in the trial.

Public health relevance
Project Narrative Despite many options available to treat breast cancer, certain subtypes of cancer are resistant to most therapy because they grow differently (i.e. triple negative breast cancer, TNBC). We propose an entirely different approach that is two pronged: (1) target the metastasis initiating cells within the tumor by depleting copper they rely on to fuel their spread; (2) target the places tumors like to spread to by altering the microenvironment that it is completely dependent on for growth and survival. If we are successful, we will have put forward a new, effective, well-tolerated and inexpensive therapy to improve outcome in triple negative breast cancer patients.